PULSE PROGRAM DEVELOPMENT AND DATA COLLECTION ON THE VARIAN SPECTROMETERS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. This time is devoted to testing and developing pulse programs on the facility's Varian spectrometers. This includes optimizing experiments for the cryogenic probe in use at NMRFAM.